IMPROVING THE ASSESSMENT OF VITAMIN B12 NUTRITION STATUS

The long-term objectives and specific aims are to develop laboratory methods which will expand the ability of health professional to diagnose and assess nutritional status with respect to folic acid and vitamin B-12, deficiencies of which are the second and third most frequent causes of nutritional anemia. The research will focus particularly on how best to screen people over 50 for the earliest stages of developing pernicious anemia and how best to screen people with liver disease and/or iron defieciency and/or hemoglobinopathy for hidden foalte or vitamin B-12 deficiency before vitamin deficiency anemia develops, therby allowing vitamin B-12 or folate treatment before need for acute care or hospitalization develops. Current radioassay and microbiologic assay methodology for measuring serum levels of vitamin B-12 and folate, and red cell folate, which misses many cases, will be compared with newer methodologies, namely, measurements of percent saturation of transcobalamin II (TC II) with Cobalamin and cobalamin analogues, and non-competitive endogenous ligand radioassays which measure number of molecules bound (competitive assays use exogenous ligand to measure competition of various analogues of a vitamin with a standard). Two new and more sensitive modifications of radioassay for antibody to intrinsic factor in urine will also be evaluated for value in diagnosis of early pernicious anemia. The value of looking for subtle hypersegmentation in granules, and of doing deocyurindine (dU) suppression tests of peripheral blood lymphocytes as well as measuring percent saturation of TC II to diagnose deficiencies of vitamin B-12 and/or folate which are missed by finding normal serum and red cell vitamin B-12 and folate will be further studied, as will measurement of the quantity of the saturated component, as well as the value of new non-competitive endogenous ligand radioassays of folate in serum, red cells, and whole blood.